RENAL ANGIOTENSIN (AT2) RECEPTOR FUNCTION

The purpose of this protocol is to determine the function of the renal AT2 receptor subtype in proximal tubule sodium and water transport in humans. Recruitment is ongoing.